The function and underlying mechanism of TET1 in myelodysplastic syndromes

PROJECT SUMMARY (ABSTRACT):
Title: The function and underlying mechanism of TET1 in myelodysplastic syndromes.
Background: Myelodysplastic syndromes (MDS) is a heterogenous group of clonal hematopoietic stem cell
disorders, characterized by peripheral blood (PB) cytopenias (e.g., anemia, leukopenia, and thrombocytopenia).
Although chromosomal abnormalities, gene mutations and some histone/DNA epigenetic changes have been reported
in MDS, the molecular mechanisms underlying the pathogenesis of MDS have not been well understood. TET1, the
founding member of the TET methylcytosine dioxygenase family, was first identified as a fusion partner of the
MLL gene in acute myeloid leukemia (AML). In contrast to the previous thought that all three TET genes
(TET1/2/3) may function as tumor suppressor genes in cancers, our recent work showed that TET1 is
overexpressed in certain subtypes of AMLs, and plays a critical oncogenic role in the development of such AMLs.
However, the role of TET1 in MDS remains unknown. Recently, in analysis of a genome-wide gene expression
profiling dataset of a large cohort of human primary MDS patients, we found that TET1 is also aberrantly
overexpressed in all the major subtypes of MDS analyzed, which was confirmed by qPCR in our in-house MDS
samples. Tet1 is also overexpressed in various murine MDS models. We then showed that knockdown of TET1
expression substantially promoted differentiation of MDS cells, and forced expression of wild-type TET1 (but not
catalytic inactive TET1 mutant) caused the opposite phenomenon. TET1 depletion also significantly inhibited
MDS progression and diminished cytopenias in vivo. Furthermore, we have identified a set of potential/candidate
target genes of TET1 in MDS, and some of them have been implicated in the pathogenesis of MDS.
Objective/Hypothesis: TET1 plays an essential role in MDS pathogenesis through epigenetically regulating
expression of a set of essential target genes.
Specific Aims: (1) To determine whether TET1 is required for the development and maintenance of MDS;
(2) To determine whether forced expression of TET1 can promote MDS development and progression, and
whether TET1 function is dependent on its catalytic activity; and (3) To decipher the molecular mechanism(s)
underlying the pathological role of TET1 in MDS.
Study Design: 1) We will conduct loss-of-function studies in genetic animal MDS models and patient-derived
xeno-transplantation (PDX) MDS models to determine whether Tet1/TET1 expression/function is required for both
development and maintenance of MDS (Aim 1). 2) We will conduct gain-of-function studies with the above MDS
models to determine whether forced expression of Tet1/TET1 can promote MDS development and progression
via a catalytic activity-dependent mechanism (Aim 2). 3) We will perform genome-wide ChIP-seq, 5hmC-seq,
and RNA-seq to identify all direct targets of TET1 in MDS, followed by the validation/functional studies of a set
of top targets of TET1 in vitro and in vivo, to elucidate the molecular mechanism underlying TET1’s role (Aim 3).

Public health relevance
Project Narrative: The major goal of this proposal is to investigate the function and underlying molecular mechanism(s) of TET1, a methylcytosine dioxygenase (also called DNA methylation “eraser”) that involves in DNA demethylation, in the development and maintenance of myelodysplastic syndromes (MDS), a common form of myeloid malignancies featured by a reduction in the number of mature blood cells (i.e., cytopenia). The success of this project will not only provide profound novel insights into the pathological function of TET1 in MDS and substantially advance our understanding of the molecular mechanisms underlying the pathogenesis of MDS, but also may identify novel therapeutic targets for the treatment of MDS. Therefore, our project is of great significance in both basic science and translational research, which may lead to the development of effective novel targeted therapeutics for the treatment of MDS patients in the near future.